Pou4f3 enhancers in hearing loss treatment

Millions of people are affected by sensorineural hearing loss caused by genetic mutations or
environmental stimuli, and currently there is no curative treatment for sensorineural hearing loss. Transcription
factor POU4F3 is essential for sensory hair cell differentiation, homeostasis and regeneration. During
development, POU4F3 is required for ATOH1 to bind to enhancers of many hair cell genes to initiate their
expression; after hearing onset, reduced transcription activity of POU4F3 due to mutations of one allele leads
to hair cell death and hearing loss (DFNA15, autosomal dominant non-syndromic hearing loss 15, in human
patients); and overexpression of POU4F3 in supporting cells stimulates hair cell fate conversion. However, the
transcription of the Pou4f3 gene is poorly understood and there is no feasible method to regulate Pou4f3
expression from the endogenous allele to treat DFNA15 or to regenerate hair cells. In this project, we will
characterize putative Pou4f3 enhancers to investigate the transcription regulatory mechanisms controlling
Pou4f3 expression and utilize these putative enhancers to stimulate Pou4f3 expression in hair cells for a
potential DFNA15 treatment or in supporting cells for a new strategy to regenerate hair cells. This work will
further our understanding of the regulatory network governing hair cell specific gene expression, develop
therapeutic treatments of DFNA15 and other forms of hearing loss associated with haploinsufficiency, and
provide a new hair cell regeneration strategy with sufficient flexibility for a variety of factor combinations.